EFFICACY OF 5-FU PLUS LEUCOVORIN W/WO INTERFERON ALFA-2A FOR COLON CANCER

Testing the effectiveness of a standard chemotherapy protocol for Duke's C colon carcinoma with an experimental protocol involving addition of interferon - ALFA injections, to the standard chemotherapy (5FU and leucovorin). This is a national multicenter study of the NSABP.